Eating and Feeding Behavior: Exploring Phenotypes and Influencing Outcomes

This year, this project focused on iteratively building and evaluating the use of virtual reality technology to teach individuals concepts related to the role of gene-environment interaction in eating behaviors. Data to evaluate the educational materials to be used in this project have been collected in internet-based surveys in several waves; 2 manuscripts are in press, 1 published, and additional manuscript preparation is underway. User testing of the virtual reality experience was completed. Additional stages of this study are ready to begin.

In a Twitter-based project we also evaluated the information environment that community members and members of the public encounter when considering nutrigenetics/nugrigenomics using quantitative content analysis. The paper resulting form this analysis is under review.